Tobacco Online Policy Seminar 2024 +

ABSTRACT
The Tobacco Online Policy Seminar (TOPS) series has established itself as a leading venue for disseminating
policy-relevant tobacco research, having hosted over 80 events in its three-year history. TOPS is a free,
multidisciplinary, biweekly Zoom-based seminar series for research with tobacco policy implications using
experimental or quasi-experimental study designs (i.e., with a well-defined counterfactual). This forum is
designed to bring together academics, students, government employees, policy researchers, healthcare
professionals, advocates, and funders, with the goal of breaking silos in tobacco policy research and providing
a platform for high-quality research to be discussed and disseminated. The ultimate goal of the forum is to
facilitate the production and sharing of knowledge to develop an effective tobacco policy framework for
improving population health. TOPS strives to be a respectful, inclusive, and diverse forum, with participants
and attendees united around the concept of presenting and learning from tobacco research using study
designs capable of producing results with a causal interpretation. TOPS is managed by an Executive Board of
four tobacco control researchers: Jamie Hartmann-Boyce, Michael Darden, Michael Pesko, and Ce Shang.
TOPS is supported by an advisory board of 37 experts in tobacco control research. Since submitting our last
R13 application (Oct. 2022), TOPS has averaged 175 participants per seminar. The aims of this conference
grant application are to: 1) continue TOPS and ensure that the series continues to showcase high-quality
tobacco regulatory and policy-relevant research; and 2) continue existing and introduce new career
development opportunities. To meet these aims, the TOPS Executive Board will meet regularly throughout the
year to continue planning and hosting TOPS seminars. The conference grant will also support the effort of a
part-time administrator to oversee day-to-day activities of TOPS.

Public health relevance
NARRATIVE The proposed grant will support current and expanded programming by the Tobacco Online Policy Seminar Series in year 2024 and beyond to facilitate the production and sharing of tobacco regulatory sciences knowledge. Thus, the proposed grant is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will ensure the Nation's capability to prevent diseases and death caused by tobacco use.